Developing a Diurnal Rodent Model for Smith-Magenis Syndrome

Abstract
Smith-Magenis syndrome (SMS) is a rare neurodevelopmental disorder characterized by low
intellectual quotient, altered sleep cycles, obesity, and behavioral problems. The major gene contributing to
SMS is Retinoic acid-induced 1 (RAI1). RAI1 is a chromatin-binding protein that participates in regulating
circadian clock genes. Every reported individual with SMS experienced circadian rhythm disturbances in
sleep/wake cycle such as daytime sleepiness, frequent nighttime awakenings, and decreased total sleep time
beginning in early childhood. SMS is also the only known genetic disorder with inverted circadian rhythm of
melatonin production. However, how RAI1 loss impairs circadian rhythms and cognitive function remains
unknown.
A major roadblock to understanding the etiology of SMS is a lack of appropriate animal models that
recapitulate circadian rhythm disturbance. Most inbred laboratory mice, in which Rai1 was deleted, are
melatonin-deficient, thus inadequate for testing this hormone’s impact. Although Rai1-knockout (KO) mice
have provided important insights into the SMS etiology, including an apparent obesity phenotype due to
hyperphagia, Rai1-KO mice do not phenocopy sleep rhythm disturbance observed in SMS patients. Contrary
to the frequent night awakening and total sleep loss seen in SMS patients, Rai1-KO mice had even better
rhythms sleeping significantly more during the resting phase than wild-type mice. Two factors could have
contributed to the striking differences between Rai1-KO mice and SMS patients; 1) differential melatonin
productions and 2) distinct neural mechanisms that generate the opposite chronotypes between the nocturnal
laboratory mice and diurnal humans.
To address the fundamental needs of diurnal models of RAI1 deficiency, we set out Rai1 gene targeting
in Nile grass rat, Arvicanthis niloticus, a diurnal rodent species. Nile grass rat is a well-established diurnal
rodent used in circadian research for almost 30 years. Leveraging on the genome sequence recently released
by the Genome10K project and CRISPR-mediated gene editing, we have generated Rai1-KO Nile grass rats,
the first genome-edited diurnal rodent to our knowledge. Importantly, the first Rai1-KO phenocopy the rhythm
disturbances as seen in SMS patients. This novel model allows us to elucidate the role of the Rai1 gene in
regulating circadian rhythms and cognitive function in diurnal animals that can be translated to humans. The
proposed project aims to thoroughly validate the specific gene deletion and perform initial behavioral
characterization of Rai1-deficient Nile grass rats, thereby providing the first diurnal animal system to study
SMS pathophysiology and a platform to test therapeutic interventions for this condition.

Public health relevance
Project Narrative Smith-Magenis Syndrome (SMS) patients exhibit circadian rhythm disturbance and unruly behavior, such as self-injury, making life difficult for patients and their families. Unfortunately, mouse models of SMS are nocturnal and lack melatonin, a key modulator of sleep, limiting their utility for elucidating the role of the causative gene RAI1 and for therapeutic inventions. The proposed research aims to develop the first diurnal animal model of RAI1 deficiency by deleting RAI1 in diurnal Nile grass rats, which will allow a better understanding of RAI1 and will lead to the development of evidence-based treatment strategies.